Chimeric antigen receptor-modified iNKT cell therapy for CD7+ malignancies

PROJECT SUMMARY/ABSTRACT
The major hurdle in developing chimeric antigen receptor (CAR)-T therapy for T-cell malignancies is
CAR-T cell fratricide by self-killing, which leads to insufficient numbers of CAR-T cells for infusion. CRISPR-
mediated genomic editing provides an alternative approach to enabling expansion of CAR transduced T cells
from allogeneic healthy donors. However, the safety and clinical implications of CRISPR-based gene editing
remain lingering. The objective of this SBIR Phase I project is to develop a non-edited, CD7 CAR-modified
allogeneic invariant Natural Killer T (iNKT) cell product for the treatment of relapsed and refractory patients
with T-cell acute lymphoblastic leukemia (T-ALL) and acute myeloid leukemia (AML). The rationale for this
study is based on our strong preliminary data. We propose two Specific Aims. Aim 1: To optimize the iNKT
cell primary stimulation for maximal proliferation and CAR transduction. We plan to test major
commercially available T-cell activation reagents, i.e., T-Cell Activation/Expansion kit (CD2/CD3/CD28
microbeads), T-Cell TransAct (CD3/CD28 microbeads), and CD3/CD28 Dynabeads in primary stimulation and
transduce them with lentivirus CD7 CAR. CD7 CAR-modified iNKT, control CD19 CAR-modified iNKT or mock
cells will be evaluated for cytotoxicity and IFN-γ production against CD7+ T-ALL and AML, CD19+ B-cell tumor
cells, and αGalCer pulsed CD1d+ target cells. In addition, expansion rate, CAR expression, and expression of
CD3 and invariant T-cell receptor (iTCR) will also be assessed. CD7 CAR-modified iNKT cells with a highest
expansion and CAR transduction while maintaining iNKT cell function and phenotype in primary culture will be
examined for expansion in secondary stimulation. Expanded final cell products will be characterized for their
expansion rate, cytotoxicity, cytokine profiling, phenotype, and expression of checkpoint receptors. Aim 2: To
determine the effect of IL-7 co-expression on enhancing CD7 CAR-modified iNKT cell survival and
efficacy. To test our hypothesis that IL-7 co-expression in CD7 CAR-modified iNKT cells can enhance their
survival and anti-tumor efficacy, we will initially examine IL-7 and/or IL-15 co-expression in CD7 CAR-modified
iNKT cells in response to CD7+ or CD7- tumor cells and characterize 1) secreted IL-7 and/or IL-15 levels, 2)
STAT5 phosphorylation to reflect IL-7 and IL-15 signaling, 3) cytotoxicity and IFN-γ release, 4) fold expansion,
5) quantification of antiapoptotic factors (Bcl-2, Bcl-xL, MCI-1), 6) serial tumor challenge assay to assess
enhanced survival, 7) frequency of naïve, central and effector memory T cell subsets, and 8) expression of
checkpoint receptors (PD-1, CTLA4, TIM3, LAG3). We will then evaluate their anti-tumor efficacy in our
established aggressive T-ALL xenograft model as assessed by reduced tumor mass via bioluminescence
imaging and prolonged survival. iNKT cell survival will also be assessed by flow cytometry.

Public health relevance
PROJECT NARRATIVE This research could be translated into development of allogeneic, off-the-shelf, non-edited, CD7 CAR-modified iNKT cell therapy for the treatment of patients with relapsed and refractory acute lymphoblastic leukemia and acute myeloid leukemia.